Healthy Living Partnership to Prevent Diabetes (HELP PD) Phase 3 (formerly TRIP)

DESCRIPTION (provided by applicant): The Diabetes Prevention Program (DPP) demonstrated that weight loss achieved through changes in physical activity and diet was more effective at preventing type 2 diabetes mellitus (DM) than a pharmacologic intervention; however, translation of the DPP into the community has lagged for multiple reasons. The Healthy Living Partnership to Prevent Diabetes (HELP PD) Trial (funded Sept. 2006 - Aug. 2011) is a translational study of 300 overweight or obese persons with pre-diabetes randomized to usual care (UC) or a group-based lifestyle intervention (LI) facilitated by community health workers (CHWs) and supported by staff of a Diabetes Care Center. To date, recruitment, retention, intervention, and assessment have been excellent and 6-month weight loss is averaging 6.4%. Since Aug. 2007, we have enrolled 258 participants, and we plan to enroll 42 more by Mar. 2009. Follow-up was funded for a uniform 2 years; hence, the earliest-enrolled participants (enrolled in Aug. 2007) will complete follow-up for HELP PD in Aug. 2009. The primary goal of this competitive renewal is to test the long-term glucose lowering effects of the HELP PD intervention by randomizing the LI group to continued group maintenance (GM) or self-directed maintenance (SM) and following the UC group for additional comparison purposes. Additional funding, partially overlapping with current funding, is requested to re-enroll participants as they complete initial follow-up, thus giving those who continue GM a seamless intervention and the opportunity to begin new follow-up visits 6 months after the final HELP PD visit for an additional 36-48 months. We will test the value of long-term GM versus an initial 2-year intervention followed by SM, with the added value of a true comparison group (UC) to define biological effects. Secondary outcomes include other biologic parameters (insulin, lipids, blood pressure, weight, waist), behaviors, and cost-effectiveness. We will have good power to evaluate the effectiveness of the HELP PD approach in maintaining glucose and weight change, and other biologic effects. Notably, follow-up in DPP was, on average, 3.2 years. If this application is approved, follow-up will be extended from 24 to 60-72 months for this cohort, and we will be able to transition into extended maintenance without a gap in intervention; hence, we are well positioned to test the proposed hypotheses. Demonstrating the longer term effectiveness of HELP PD represents a key step in establishing the value of this approach to translation of DM prevention into the community. This crucial evidence will be used to support reimbursement policy for DM prevention, dissemination of the HELP PD CHW approach and generalization to other behaviorally influenced chronic diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: In light of the increasing rates of incidence, prevalence, and overall public health burden, the prevention of diabetes is a critical public health issue. This project is testing the impact of a long-term maintenance approach following an existing diabetes prevention translational study (HELP PD) on measures of diabetes risk. Although preliminary data indicate that HELP PD has been successful at inducing short-term weight loss, the proposed project aims to examine the impact of long-term maintenance of weight loss on diabetes prevention. Project Narrative In light of the increasing rates of incidence, prevalence, and overall public health burden, the prevention of diabetes is a critical public health issue. This project is testing the impact of a long-term maintenance approach following an existing diabetes prevention translational study (HELP PD) on measures of diabetes risk. Although preliminary data indicate that HELP PD has been successful at inducing short-term weight loss, the proposed project aims to examine the impact of long-term maintenance of weight loss on diabetes prevention. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Multiple studies have demonstrated that behavioral lifestyle interventions can produce clinically meaningful weight loss. Indeed, the Diabetes Prevention Program (DPP) demonstrated that weight loss achieved through changes in physical activity and diet was more effective at the prevention of type 2 diabetes mellitus (DM) than a pharmacological intervention. However, a consistent finding across numerous weight loss studies is that despite initial short-term weight loss, many persons regain that weight over time and typically return to baseline weight. The development of cost-effective interventions to promote maintenance of glucose lowering and weight loss has been recognized as a critical research priority. The Healthy Living Partnership to Prevent Diabetes (HELP PD) project has successfully translated the DPP lifestyle weight loss intervention into a low cost, community-based weight loss program administered and delivered through a local Diabetes Care Center (DCC) and led by community health workers (CHW). Our preliminary results indicate that participants in the HELP PD lifestyle intervention (LI) program have met initial weight loss goals during the intensive 6-mo phase (Phase 1) and have demonstrated maintenance of weight loss during the first half of the 18-mo maintenance phase (Phase 2). We are blinded to glucose change and other biological changes and will, therefore, send our planned interim analysis to the study section as a supplement prior to review. We are well positioned to test our original hypotheses regarding the effect of the intervention over 24 months. In this application we demonstrate that we are also in a unique position to examine longer-term maintenance of glucose lowering and weight loss. The approved 18-mo maintenance phase is a relatively short maintenance period and, without this renewal, we will not be able to examine longer-term maintenance of glucose lowering and weight loss achieved through this translational approach. Therefore, the primary goal of this competitive renewal is to test the longer-term glucose lowering effects of the HELP PD intervention by randomizing the LI group to continued CHW-led group maintenance (GM) or self-directed maintenance (SM) and following the usual care (UC) group for additional comparison purposes. Participants who have completed the HELP PD study will be re-consented and followed for an additional 3-4 yrs (Phase 3). New funding, partially overlapping with current funding, is requested to re-enroll participants as they complete initial follow-up, thus giving those who continue GM a seamless intervention and the opportunity to begin new follow-up visits 6 months after the final currently approved HELP PD visit for an additional follow-up of 3-4 yrs. We will test the value of long-term GM versus an initial 2-year intervention followed by SM, with the added value of a true comparison group (UC) to define biological effects. This design will enable us to examine the effectiveness of our group-based, CHW-led approach as compared to a self maintenance condition on the long-term maintenance of glucose lowering, weight loss and other clinical effects. Additionally, we will be able to examine the impact of weight regain, should this occur, on important metabolic outcomes. Aim 1: To test the hypothesis that long-term continuation of a group based weight loss lifestyle maintenance intervention (GM) delivered and administered through a diabetes prevention program model will have more beneficial and clinically meaningful impact on glucose and insulin metabolism and markers of the metabolic syndrome than either self maintenance (SM), or usual care (UC). 1. The primary outcome is change in fasting glucose. 2. The secondary outcomes will consist of intermediate outcomes (physical activity, dietary intake, weight, and waist circumference) and tertiary outcomes will consist of other longer term outcomes (metabolic syndrome status, insulin, homeostasis model measurement of insulin resistance, triglycerides, HDL-C, blood pressure, and health-related quality of life). In addition, we will monitor the incidence of diabetes and serious adverse events as participant safety concerns. Aim 2: To conduct an economic evaluation of the program in order to determine the cost effectiveness of the longer-term maintenance in terms of the primary and major secondary (DM prevention) outcomes. Aim 3: To investigate whether intervention effects on outcomes (e.g., fasting glucose) differ by selected characteristics of participants (age, gender, and ethnicity) and/or are mediated through changes in constructs from social cognitive theory, behavior change (i.e., diet and physical activity), and/or biological impact measures (weight, waist). This project will provide critical information regarding the effectiveness of extended group maintenance in a community-based, lifestyle intervention compared to no extended maintenance and usual care for the prevention of type 2 DM. If approved, total follow-up will be extended to 5-6 yrs. for this cohort and we will be able to transition into extended maintenance without a gap in intervention; hence, we are well positioned to test the proposed hypotheses. Should the continued GM approach elicit improved success for the maintenance of glucose lowering and weight loss compared to the SM approach, this information would support the development of community-based interventions with extended support for maintenance of healthy behaviors. This evidence is critical to implementation of a successful dissemination approach, because it is critical to know whether longer-term maintenance is beneficial, or even required, to maintain clinically important benefits, Because many chronic diseases are influenced by physical activity and dietary intake, this approach should translate into public health benefits in the prevention of diseases other than type 2 DM, such as obesity, hypertension, cardiovascular health and cancer prevention, thus greatly multiplying the potential benefits for society and serving as a model for community-based health promotion programs. The evidence generated in the proposed continuation of the HELP PD Trial will be critical to determining the most effective model for dissemination of the HELP PD approach. Our current results provide moderately strong evidence of early weight loss and modest evidence of medium-term maintenance of weight loss. Early evidence regarding glucose lowering and other biological effects will be provided based on additional analyses of masked data prior to review and in keeping with our intent to maintain as much masking of investigators as possible. While we are in an excellent position to complete the trial as originally planned and funded, we believe the new knowledge generated in this continuation period regarding the best approach to long-term maintenance will be critical to dissemination. Will 2-years of intervention be sufficient to ingrain lifestyle change, such that subsequent self-directed maintenance is sufficient to preserve a differential in glucose and weight from usual care? Will longer-term CHW-led group maintenance be more effective than self-directed maintenance? If so, what are the cost implications of these strategies? What reimbursement policies will be needed? If funded, this continuation phase will provide us with the evidence needed to address these critical aspects of program dissemination.